The function of wide-field amacrine cells in mammalian retina

The trophoblast glycoprotein (TPBG, aka oncofaeto protein, 5T4) is restrictively expressed in adult retina
in rod bipolar cell and the wide-field GABAergic ON/OFF amacrine cell, TH2-AC. Knocking out the Tpbg
gene in mice does not alter scotopic or photopic ERG responses but photopic contrast sensitivity was
enhanced, indicating that TPBG in TH2-AC participates in retinal information processing through
unidentified mechanism. We have found that TH2-AC intrinsic excitability is enhanced in the absence of
TPBG. We hypothesize that TPBG regulates TH2-AC excitability and that TH2-AC regulates retinal circuits
responsible for contrast and/or motion encoding. Given that amacrine cell is the most diverse but lthe
east understood retinal neuron thus far, studying TPBG in TH2-AC provides a rare opportunity to
understand how wide-field amacrine cell works in the mammalian retina. We will use mouse genetics
and electrophysiological approaches to 1) Use the DATIRESCre driver mouse line to manipulate TH2-AC to
understand the molecular and cellular basis of the enhanced photopic contrast sensitivity phenotype of
the Tpbg knockout animals (Aim-1) and 2) Genetically and/or virally ablate TH2-AC from retina to study
how retinal contrast and motion encoding are affected at the behavioral level by OKR and at the cellular
level in TH2-AC’s eight postsynaptic RGC partners (Aim-2). Completion of these independent aims will
lead to a better understanding on how a wide-field amacrine cell works in a mammalian retina.

Public health relevance
The retina detects, computes, and transmits visual information to brain through intricate synaptic networks among five major neuronal types: photoreceptors, horizontal cells, bipolar cells, amacrine cells, and retinal ganglion cells. Amacrine cell is the most diverse but least understood retinal neuron. This study will use a multidisciplinary approach to investigate the role of a wide-field amacrine cells called TH2-AC in contrast and motion detection during daytime. Success of the study will bring better understanding on information processing in retina and will benefit current and future therapeutic attempts in treating human blinding diseases.